Contribution of C4b-binding protein to interactions of Neisseria gonorrhoeae with human neutrophils

ABSTRACT
Neisseria gonorrhoeae (Gc) is the causative agent of the sexually transmitted infection gonorrhea. With an
estimated 87 million cases worldwide annually, increasing resistance to last-line antibiotics, and no protective
vaccine, Gc is an urgent public health concern. Investigating Gc-host interactions is crucial to identify new drug
targets and decrease the global burden of disease. The host response to Gc is highly inflammatory and drives a
robust influx of neutrophils to the site of infection. To persist in its obligate human host, Gc has evolved strategies
to evade the innate response and survive neutrophil exposure, including sequestration of host proteins for
protection. Our lab recently reported that in the absence of all other complement factors, human complement
inhibitor C4b-binding protein (C4BP) from serum binds outer membrane protein porin on Gc and reduces killing
and phagocytosis by neutrophils. However, the molecular mechanisms underlying the complement-
independent role of C4BP in protecting Gc from neutrophil killing remain undefined. The overarching goal
of this fellowship proposal is to define the molecular mechanisms driving complement-independent protection of
Gc by C4BP during neutrophil interaction. One crucial interaction at the Gc-neutrophil interface is binding of Gc
Opacity proteins (Opa) to selected human carcinoembryonic-antigen related adhesion molecules (CEACAM).
Opa proteins are Gc surface proteins that act as adhesins and invasins via interaction with CEACAMs, which
are a family of immunoglobulin domain-containing receptors present on neutrophils and other cell types.
Importantly, C4BP-mediated protection from neutrophils is restricted to Opa-expressing Gc. My preliminary data
suggests that C4BP interrupts interactions between Opa and CEACAM3, which is a neutrophil-activating
receptor, but not CEACAM1, which is canonically inhibitory. I hypothesize that C4BP enhances Gc survival
by blocking stimulatory Opa-CEACAM interactions to modulate neutrophil signaling and prevent
antimicrobial activities. To evaluate the molecular mechanisms of C4BP’s complement-independent, protective
role against killing by neutrophils, I propose two Specific Aims: 1) Evaluate how CEACAM3 binding and signaling
initiation are impeded by C4BP binding to Gc and 2) Define the consequences of C4BP on Gc and neutrophil
outcomes over time. I will use a combination of targeted and unbiased approaches to dissect these mechanisms
and define the contributions of C4BP to Gc-neutrophil interactions. Completion of this project will reveal the
molecular mechanisms responsible for the complement-independent protection of Gc by C4BP, provide valuable
insight into the success of Gc within its obligate human host, and uncover potential pathways that could be
exploited by emerging C4BP-based therapeutics. The proposed studies will provide me with rigorous training in
the study of host-pathogen interactions, which will help me achieve my goal of becoming an independent
academic investigator in microbial pathogenesis.

Public health relevance
PROJECT NARRATIVE Neisseria gonorrhoeae (Gc), responsible for approximately 87 million cases of gonorrhea annually, poses a significant public health concern due to its increasing resistance to last-line antibiotics, serious clinical sequelae, and no protective vaccine. This work will define molecular mechanisms driving a non-canonical, complement- independent role of human C4b-binding protein (C4BP) in protecting Gc from neutrophils. The research outlined in this proposal will enhance our understanding of the host-specific mechanisms Gc uses to protect itself from neutrophils, reveal potential targets for C4BP-based therapeutics, and provide me with the rigorous training necessary to become an independent investigator in the field of host-pathogen interactions.